NEUROCOGNITIVE AND BEHAVIORAL CORE

The Neurocognitive and Behavioral Core (NB Core) supports all three Projects. The Core will perform the development, provide training and supervise the collection and scoring of a common set of evaluations that will be done across the two Clinical Projects( 1 and 2). Based on the results and experiences with the proposed behavioral tasks, the NB Core will work to design tasks appropriate for future functional neuroimaging studies that would be part of a mature center. Additionally, the Core will organize and manage data from all three Projects, to allow the analysis of findings across species and Projects. This process will be facilitated by the involvement of Project and Core Pis, led by co-Pi of the Center, Dr. Carroll.